Understanding Breast Cancer Risk and Screening in Transgender Persons through a Pilot Breast Cancer Screening Program

PROJECT SUMMARY/ABSTRACT
In the U.S., an estimated 1.4 million people identify as transgender (TG), defined as a person whose gender is
different than their sex assigned at birth, and are a designated minority population by the NIH (NOT-MD-19-001).
Many TG persons take gender-affirming hormone therapy, usually estrogen or testosterone based, to alter their
physical appearance and improve their psychological health. Lifetime exposure to estrogen is a well-established
risk factor for breast cancer (BC). Despite a growing TG population, the risk of developing BC in TG persons is
unclear and there is no consensus on how to ideally screen this undeserved population for BC. These knowledge
gaps prevent informed decision-making among healthcare providers and TG persons, likely contributing to the
cancer disparities observed in the TG community. The overarching goal of my research agenda is to develop
evidence-based TG BC screening guidelines. The proposed K08 will begin to fill critical knowledge gaps. In
collaboration with our LGBTQ+ Inclusion Health Clinic, we will establish a pilot BC screening program and utilize
a mixed methods approach to explore BC risk and screening in this population. These data will provide the
necessary foundation to develop a multi-institutional longitudinal TG BC screening cohort study which will inform
the development of BC screening guidelines and best practices for BC screening within the TG community. The
foundational K08 work will be accomplished through three specific aims: 1) determine the callback and biopsy
rates of TG persons after screening mammography and automated breast ultrasonography, 2) assess
perceptions towards BC risk, screening, and the screening experience of TG individuals through surveys and
interviews, and 3) identify individual and systems-level barriers to BC screening for TG persons and methods to
optimize the screening process through interviews and focus groups. These findings will provide the first-ever
prospective scientific data on screening mammography and automated breast ultrasonography lesion detection
in TG persons. The qualitative data from Aims 2 and 3 will identify individual and systems-level barriers to
screening and opportunities to improve the screening process and experience. The research proposal is
complemented by a comprehensive and distinctive training plan focused on mixed methods and survey research,
gender studies, database development, and cohort recruitment and retention. In combination with my diverse
and collaborative mentorship team, this study and training plan is designed to optimize my seamless transition
to becoming an independently funded surgeon–scientist and my efforts to mitigate BC disparities in TG persons
through a 3-step process. The novel pilot BC screening study (Step 1) will provide the necessary preliminary
data and experience to submit an R01 application to develop a multi-institutional longitudinal TG BC screening
program (Step 2) which will definitively establish the lifetime risk and incidence of BC to inform the development
of evidence-based BC screening guidelines for TG persons and best practice guidelines (Step 3).

Public health relevance
PROJECT NARRATIVE This application addresses a critical gap in the literature by providing critical foundational data to extend our knowledge of breast cancer (BC) risk among transgender (TG) individuals and begin to inform TG BC screening guidelines. This project will also extend the applicant’s knowledge, skills and experience supporting a successful career as a surgeon–scientist. Next steps include an R01 application to develop a multi-institutional longitudinal TG breast cancer screening program to definitively establish lifetime risk and incidence of BC development, provide evidence-based BC screening guidelines for TG persons, and address eliminating barriers to BC screening access and delivery for TG persons.